Intracardiac beating heart tricuspid valve repair via robotics.

Summary
About 2.5% of the US population has a valvular heart disease. While neglected for a long time, problems related
to the tricuspid valve affect more than 70 million people worldwide. Among these, more than 1.6 million are in the
US. The yearly incidence is about 200,000 with a 1-year mortality rate of 36.1%.
The most common problem is tricuspid valve regurgitation. The majority of tricuspid regurgitation cases are treated
surgically via prosthetic ring annuloplasty in open surgery. However, open surgery approaches introduce risks of
perioperative complications and require long recovery times. A large percentage of the population with tricuspid
regurgitation cannot receive surgical treatment because of the high-risk profile. Few patients undergo isolated
tricuspid valve surgery because the challenging anatomy of the tricuspid valve and lack of clinical experience has
hindered progress in this area.
Therefore, there is a clinical need for novel approaches that would allow tricuspid valve repair in high-risk patients
without complications associated with open-heart surgery. The intracardiac surgical applications for tricuspid valve
repair present a unique set of challenges: small scale, large deformations (beating heart), pulsatile blood flow,
and remote location from the entry access.
Percutaneous approaches rely on catheters, however, current endovascular catheter-based platforms provide
limited distal dexterity, lack sensor feedback, and cannot apply a significant amount of force. Robotic technologies
can address these challenges, yet their application in beating heart surgery is underexplored.
This proposal aims at developing a robotic platform for intracardiac tricuspid valve repair. In prior work, the
PI and Co-Is have developed a robotic platform for transcatheter beating heart procedures. We successfully
assessed the robot performance in-vitro and ex-vivo. Further, preliminary data show initial success in-vivo.
Building upon these exciting results, this proposal aims to optimize the platform to perform percutaneous tricuspid
valve annuloplasty.
The proposal articulates in three aims. Aim 1 focuses on optimizing the design of the robot to enable navigation
from subclavian vein access and implantation of an annuloplasty band to cinch the annulus. Within Aim 2, we will
develop a magnetic localization system to allow real-time tracking of the robot’s position for closed-loop control
of the robot. A distal soft sensor will monitor interaction forces with the surroundings, help confirm contact with
anatomical structures, ensure continuous contact during deployment of annuloplasty coils, and enable haptic
feedback to the user. Aim 3 will focus on validation in-vitro, ex-vivo, and in-vivo. These validations will be designed
to ensure safety of the device as well as its ability to perform sequential placement of annuloplasty coils on a
tricuspid valve annulus and enable controllable cinching on the annulus.

Public health relevance
Narrative Valvular heart disease affects approximately 2.5% of the US population, with tricuspid valve problems affecting over 70 million people globally and 1.6 million in the US. Surgical treatment for tricuspid regurgitation is associated with perioperative complications and lengthy recovery times, making it unsuitable for high-risk patients. This proposal aims to develop a robotic platform for percutaneous beating heart tricuspid valve repair which would benefit not only high-risk patients unsuitable for open surgery but also enable clinical translation and development of transcatheter procedures beyond patients contraindicated for surgery.